Detectability of Epidemics from Over-the-Counter Sales

DESCRIPTION (provided by applicant): The overall goal of this research is to improve disaster management though early detection of outbreaks of disease. We will contribute to this goal by conducting basic research that identifies over-the-counter (OTC) healthcare products whose sales correlate and precede clinical events such as hospital admissions. The results of the research will find immediate application in the National Retail Data Monitor, an existing system that monitors sales of OTC healthcare products that was developed by our laboratory. The proposed research will answer questions about which over-the counter (OTC) healthcare products to monitor for which types of diseases, and how large and sudden must an outbreak be to be detectable over background. This proposal has the following specific aims: 1. To discover new OTC healthcare product categories for use in public health surveillance by searching the very large space of OTC product categories for those that best correlate with a range of diseases and to refine the OTC product categories in current use 2. To measure the time when naturally occurring disease outbreaks are detected from sales of the best OTC healthcare product categories (as determined by product screening studies) relative to the time when they are detected from other types of surveillance data. 3. Determine the smallest increase in sales of the best OTC healthcare product categories (as determined by product screening studies) above baseline that we can detect by studying the ability of different outbreak detection algorithms to detect simulated outbreaks that we add to the sales data. 4. Determine whether what is known about self-treatment behavior is consistent with results of correlation studies by interviewing manufacturers of market-leading products in each category about their marketing research (Manufacturer Interviews) The research team has worked in this and closely related areas for the past four years and as a result have assembled a unique set of resources for this study. These resources include sets of retail data, sets of reference disease data, and analytic methods.